Role of dopaminergic signaling on anesthesia-induced retrograde amnesia

Summary
Forgetting is a familiar phenomenon, but the neurobiological underpinnings of this process remain unclear. Many
memory disorders, including retrograde amnesia, involve the inability to recall certain memories. Retrograde
memory loss affects memories formed before the onset of an event. This event can be acute and include
anesthesia, alcohol intoxication, head trauma, seizures, or chronic, like senescence and neurodegenerative
diseases. Drosophila has served as an excellent animal model when studying memory and memory loss, as
they can form strong olfactory memories through classical conditioning. Retrograde amnesia induced by an acute
event can be modeled in Drosophila. Fruit flies experience retrograde amnesia of a conditioned response when
anesthetized with a cold shock (a rapid temperature change). The mushroom body is a critical brain structure
involved in forming, storing, and retrieving these olfactory memories. The axon terminals of dopaminergic
neurons projecting to specific compartments within the mushroom body convey the aversive unconditioned
stimulus during learning. Surprisingly, these same dopaminergic neurons also regulate forgetting. The
bidirectional regulation of memory by dopaminergic neurons is mediated by two distinct receptors, dDA1 for
learning and DAMB for forgetting. Despite understanding a potential signaling pathway involving
dopaminergic neurons that regulates normal forgetting, it remains unknown if anesthesia-induced
amnesia is an active process dependent on dopamine signaling. To address this question, this proposal will
1) use in vivo imaging to characterize individual dopaminergic neurons’ dynamics of responses during
anesthesia. 2) Characterize the cellular and circuit basis of dopaminergic activity during anesthesia. 3) Evaluate
whether dopaminergic signaling is required for anesthesia-mediated amnesia. The long-term goal of this
proposal is to gain knowledge on the neurobiological basis of insult-induced memory loss. This study
may uncover novel mechanisms of anesthesia-induced amnesia. In addition, this study will provide a deeper
insight into the biological mechanisms and cognitive consequences of the use of anesthetics.
This proposal is highly significant because there is a big gap in our knowledge of the neurobiological basis of
insult-induced amnesia. Despite an increasing interest in understanding the neurobiological mechanisms of
active forgetting, we need to determine if insults like anesthesia induce amnesia through an active process.
In addition to the scientific component, this proposal includes a comprehensive plan for professional and
personal development. Aligned with the long-term objective of becoming an effective investigator and mentor
capable of sustaining a robust research program and nurturing future generations, the proposal outlines
strategies to enhance communication skills, both in scientific writing and oral presentation, as well as to cultivate
effective mentoring abilities. Recognizing these as indispensable qualities, the proposal aims to refine and
strengthen these skills over the duration of the award period.

Public health relevance
Narrative Understanding memory systems, particularly the active, biological process of forgetting, is a core area of research that can lead to cutting-edge treatments for neurological disorders. This proposal will examine if labile memories vulnerable to degradation by different insults, such as anesthesia, are an active process mediated by dopaminergic signaling. Using Drosophila as our model, the present study will provide indispensable knowledge on anesthesia-induced retrograde amnesia.